SBIR PHASE II: TOPIC 41, CARDIOVASCULAR, LUNG AND BLOOD COMPUTATION MODEL LIBRA

Develop a repository of human cardiovascular and cardiopulmonary computer models consisting of realistic, image-based anatomic models of large arteries and airways, generic, distal vascular beds, and representative blood and tissue properties. Simulations based on repository data will have significant impact on our understanding of cardiopulmonary pathologies, diagnostic methods and therapy development, and ultimately, allow physicians to design optimal, prearsonalized treatment plans based on predictive methods. The project will yield a critical data resource for scientist, engineers, industry and physicians seeking to use simulation methods to aid in preventing, diagnosing and treating patients with cardiopulmonary dieseases.